Montana Tech Training Project Grant Application

Project Summary
Montana Technological University is commonly referred to as “Montana Tech” and will
be denoted as such throughout this proposal narrative. This proposal is for a single TPG
supporting two academic training programs; one conducted at the undergraduate level,
and the other conducted at the graduate level:
1. Undergraduate: BS Occupational Safety and Health Academic Training Program,
2. Graduate: MS Industrial Hygiene Academic Training Program which includes:
a. MS Industrial Hygiene campus degree program (referred herein as MS IH
Program), and the
b. MS Industrial Hygiene Distance Learning/Professional Track degree program
(referred herein as MS IH Distance Learning Program)
The three degrees are currently supported by our most recent TPG application;
however, they were previously submitted as a single academic training program. Our
revised approach which seeks support for two academic training programs is intended to
enhance the clarity of our application. All programs are managed and housed in the
Safety, Health, and Industrial Hygiene (SHIH) Department. Five faculty members in the
Department are substantially involved in teaching and research, while one faculty
member serves in a part-time program management role. The SHIH Department faculty
work harmoniously to achieve department and degree program goals and objectives.
The five faculty members are considered key personnel for both training programs.
The primary goal of our training programs is the education of capable graduates to help
meet the ever-growing demand for health and safety leadership in the U.S. This goal is
supported by four updated objectives: 1) maintaining high quality inclusive curricula to
meet the diverse needs of our constituents, 2) managing programs to enhance
enrollment and graduate placement numbers and to promote diversity within our
programs, 3) developing engaging student experiences, both professional and research-
based, and 4) sustaining high quality faculty. The continued development of our
programs is helping to meet a strong industry demand for well-trained OSH and IH
professionals in a region that has a small number of programs. The growth of our MS IH
Distance Learning Program has expanded beyond a regional presence with successful
graduates employed throughout the US. This outcome translates directly to the urgent
need for well-prepared OSH and IH professionals, particularly in the Mountain West
region.
The NIOSH TPG grant provides funds for valuable program enhancement, primarily
through student scholarships. We propose to support 14 undergraduate students
through the BS OSH Academic Training Program and 13 graduate students (5 MS IH
and 8 MS IH Distance Learning) through the MS IH Academic Training Program per
year. Additional enhancements include student conference registration, student travel,
and faculty development. The anticipated duration for trainee support is 1-3 years, with
exceptions being kept within term restrictions provided by NIOSH. NIOSH support
unquestionably enhances program quality and recognition, which in turn supports our
primary goal of producing capable OSH and IH graduates.

Public health relevance
Relevance to Public Health The Montana Tech Safety, Health and Industrial Hygiene Department provides high quality, accessible, science and technology curricula and research opportunities designed to prepare students for successful OSH and IH careers. This is especially relevant to our public health because the burden of occupational injuries and illnesses in the U.S. has been estimated to be similar to the burden from cancer and exceed that of AIDS, Alzheimer’s disease, and arthritis.1 Despite the tremendous burden that occupational injuries and illnesses have on our society, fewer than half of the anticipated OSH professionals needed in the U.S. are anticipated to graduate in the coming years.2 We’ve been working hard to meet this demand since our first program was established in 1975 and we continue to grow and produce more qualified graduates thanks in large part to the support of the NIOSH TPG program.